A platform to identify in vivo targets of covalent cancer drugs in 3D tissues

Abstract
Covalent inhibitors represent some of the most successful drugs in human history, including aspirin and
penicillin. Recently, targeted covalent drugs have taken center stage as a compelling approach for achieving
major goals in oncology that have proven elusive for more classical reversible small molecules, including, for
instance, the selective inactivation of oncogenic kinases (BTK, EGFR, FGFR, JAK3) and, most notably, the
inhibition of the once-deemed undruggable KRAS protein. We are now in the midst of a resurgence of interest
in covalent drugs for their demonstrated capability to engage cancer targets that have been historically
considered undruggable. However, despite their proven success and inherent advantages of potency, there
has been a general reluctance to develop covalent drugs due to the concern of potential irreversible off-target
toxicity across different organ systems. Hence, a comprehensive understanding of both on and off-targets in
vivo is critical for covalent drugs. Currently, it is impossible to determine drug binding across a whole animal
with cellular and molecular resolution in mammals.
Building upon a recent breakthrough in tissue imaging termed CATCH (Clearing-Assisted Tissue click
Chemistry), we propose to develop a general platform for in vivo imaging of drug-target interactions with
unprecedented spatial precision by integrated applications of high-resolution whole-body imaging and
chemoproteomics (such as Activity-Based Proteomic Profiling, or ABPP) through the same covalent probes.
This way, every cell in a living mammal targeted by the drug (both on- and off-target) can be revealed in situ
and registered onto a defined protein map to screen and identify in vivo drug targets. The data stream
generated by this platform could rapidly link the rich knowledge of drug affinity to the therapeutic index,
therefore accelerating the translation of chemical activities into cancer therapies.
Our team has well-established and complementary expertise in chemoproteomics and tissue imaging to
ensure the successful execution of the project. In this IMAT R33 application, we plan to further develop
CATCH to profile in vivo targets of covalent kinase inhibitors. First, we will adapt CATCH to 3D somatic tissues
(Aim 1). Next, we will expand CATCH to an array of covalent BTK (Bruton’s tyrosine kinase) inhibitors (Aim 2).
Finally, we will profile dose-dependent in vivo cellular targets of BTK inhibitors in the mouse cardiovascular
system (Aim 3). We anticipate that these studies will establish in vivo CATCH methods for identifying targets of
covalent BTK inhibitors to better understand their efficacy and toxicity. More generally, the established platform
can be broadly applied to any covalent cancer drug for unbiased in vivo target identification. The pipeline,
analytics, and high-resolution drug target data will be rapidly disseminated for public access and exploration,
releasing an immediate, direct, and profound impact on covalent cancer drug discovery and refinement.

Public health relevance
Project Narrative Recent breakthroughs in targeted covalent inhibitors are revolutionizing the treatment and prognosis of many cancers, however, people have been reluctant to develop new covalent inhibitors due to the fear of off-target toxicity. This proposal aims to combine chemoproteomic and tissue imaging approaches to establish a 3D, whole-body platform for comprehensive identification of on- and off- targets of covalent drugs in vivo. The resulting technologies and data will have an immediate and transformative impact on the development and refinement of cancer therapies.